Molecular Origins of Phenotypic Changes in the Obese Microvascular Endothelium

PROJECT SUMMARY
Obesity is a major risk factor for cardiovascular diseases (CVD) such as atherosclerosis, hypertension, type 2
diabetes and stroke. Although it is well documented that EC dysfunction is present in most forms of CVD, the
mechanisms by which obesity shapes the development of EC dysfunction remains poorly understood. Further
complicating the understanding of EC dysfunction is the heterogeneity of ECs throughout the vasculature.
Recent studies have demonstrated a large degree of divergence between EC subtypes in the macrocirculation
(aorta) that can be further altered with obesogenic diets over a short period of time. Our lab and others have
shown that the microvasculature is particularly susceptible to obesity induced dysfunction and is a key predictor
of end-organ damage. In the microvasculature of obese mice, we have shown a striking increase in NADPH
oxidase 1 (NOX1) and histone deacetylase 9 (HDAC9), two molecules that have been shown to be important
contributors to endothelial dysfunction and phenotypic changes, respectively. As of the writing of this proposal,
no studies have been conducted to elucidate the heterogeneity of EC in the microcirculation, not to mention the
effect of obesity on these populations or whether or not NOX1 and HDAC9 are preferentially expressed in certain
populations over others. To perform these experiments in a time and cost effective manner, we have developed
an AAV approach to deliver AgRP, an orexigenic peptide, specifically to the brain to induce hyperphagia and
obesity. This novel approach in conjunction with endothelial specific lineage tracing mice and endothelial specific
HDAC9 knockout mice will facilitate testing of our central hypothesis that obesity alters EC heterogeneity in the
microcirculation to favor inflammatory EC phenotypes expressing NOX1. Aim 1 will define, through an obese
endothelial specific lineage tracing model, the transcriptomic and phenotypic changes underlying loss of
endothelial function in the microcirculation of obese mice. Using single cell RNA sequencing of fate mapped ECs
from lean and obese mice, we will elucidate the subtypes of ECs expressing NOX1 and interrogate co-expression
patterns. Aim 2 will test the hypothesis that HDAC9 has a causal role in increased expression of NOX1 and
microvascular endothelial dysfunction and that weight loss reverses the expression of HDAC9 and NOX1 and
restores endothelial function. We will assess in vitro and in vivo, whether HDAC9 drives the expression of NOX1
and whether its deletion ameliorates endothelial dysfunction in obesity. We will also investigate the effects of
weight loss on microvascular endothelial function using a novel floxed AgRP AAV that enables cessation of
AgRP expression with the goal of promoting weight loss. We anticipate the findings of this proposal will reveal
new mechanisms contributing to endothelial dysfunction in obesity and will provide insight into potential
therapeutic targets to improve cardiovascular health.

Public health relevance
PROJECT NARRATIVE The studies proposed in this application will examine the landscape of microvascular endothelial cell phenotypes in obesity as well as investigate the role of HDAC9 in microvascular NOX1 expression and endothelial dysfunction in obesity. We will employ a novel AAV model of hyperphagia and obesity that can be easily combined with genetic models of endothelial lineage tracing and endothelial HDAC9 deletion to test the hypothesis that obesity upregulates HDAC9 to alter endothelial cell heterogeneity to favor loss of function, inflammatory phenotypes expressing NOX1. These studies will identify new mechanisms and paradigms by which endothelial dysfunction develops in obesity which may guide future therapeutic strategies to improve cardiovascular health.